Development of Mutant Specific Antisense Oligonucleotides for TARDBP and KIF5A as a Therapeutic for ALS/FTD

Project Summary / Abstract
Successful development of gene-based therapeutics, including gene delivery and RNA interference
(RNAi)-based therapies, requires establishing the mechanism by which gene mutations contribute to
pathogenesis. For instance, therapeutics for Loss of Function (LoF) mutations will be focused on
increasing gene expression, possibly through viral gene delivery. The development of gene-based
therapies for dominant disorders based on Gain of Function (GoF) or Dominant Negative (DN)
mechanisms is more complex. For GoF mutations, researchers have mainly focused on using RNAi
to knockdown gene expression that targets both the mutant and wild-type allele. However, in many
cases, the reduction of the single wild-type allele may have deleterious consequences. For DN
diseases, knockdown of both alleles will unlikely be successful as the ratio of mutant:wild-type protein
is not expected to change. One method to overcome these limitations is to develop RNAi that are
specific to the actual mutation, however, single base pair discrimination is technically very challenging
and would require a different therapeutic for each mutation. Based on these premises, there is a dire
need to develop mutant-specific RNAi for the therapeutic treatment of diseases resulting from
dominant mutations with a GoF or DN pathogenic mechanism. We have recently developed a novel
method for mutant specific RNAi which overcomes the limitations described. Here, we will focus on
advancing this technology through the comprehensive development of therapeutics for ALS/FTD. The
objective of this application is to identify and develop potential therapeutics for the allele-specific
knockdown of mutant alleles in the TARDBP and KIF5A genes which are causative for ALS/FTD. To
test our hypothesis, we have designed two specific aims: (1) To Design and Evaluate Allele-
Specific ASOs for TARDBP/KIF5A. ASOs spanning target regions will be tested for mutant-specific
knockdown within isogenic iPSC-derived cortical neurons (iCNs) harboring either TARDBP or KIF5A
mutations. Further modifications will be incorporated as needed to improve allelic discrimination,
potency, and possible toxic effects. (2) To Evaluate the Rescue of Allele-Specific ASOs in Mutant
TARDBP/KIF5A iCNs. IPSc-derived neurons harboring mutant TARDBP/KIF5A display alterations in
gene expression, alternative/cryptic splicing, nucleocytoplasmic transport, and survival. Here, we will
evaluate the rescue of these defects by mutant specific ASOs to isogenic iCNs harboring mutations in
TARDBP/KIF5A. Impact: This study will provide a comprehensive development of allele specific-
ASOs (AS-ASOs) for mutations in TARDBP/KIF5A. Undoubtedly, AS-ASOs will have broad
applications for therapeutic development across numerous genes contributing to ALS and numerous
other human diseases.

Public health relevance
Project Narrative The development of therapeutic RNAi which reduces expression of both normal and mutant alleles is not appropriate in many cases for dominantly inherited disorders. As such, there is a dire need to develop mutant-specific RNAi as a therapeutic treatment for such diseases. Here, we will execute the comprehensive development of a novel approach for the allele-specific knockdown for mutations in the TARDBP and KIF5A genes which are causative for ALS/FTD.